Developing a trauma-focused intervention for older adults living with HIV

Project Abstract
The PI’s long-term goal is to develop trauma-focused interventions that will improve mental health, HIV care
outcomes along the treatment cascade, and overall health-related quality of life (HRQoL) for older populations
living with HIV. Her short-term career goals were to: 1) Acquire knowledge about the main facets of trauma-
focused intervention development addressing childhood sexual abuse (CSA) among older adults living with HIV;
2) Attain additional training in mixed-methods research and apply to formative work for intervention development;
3) Learn more about HIV and aging, and application of gerontological theories to research; 4) Learn more about
the syndemic of CSA and HIV; and 5) Obtain additional training in longitudinal data analysis for clinical trials
such as mixed-effect modeling and longitudinal mediational analysis. As an epidemiologist, the PI has a strong
background in advanced epidemiologic research methods, and has experience in doing research among
populations living with HIV. Nevertheless, to become an independent researcher in interventions for older people
living with HIV, she required additional training, which can be obtained through the K01 award. As a result, the
PI has received training from mentors, workshops, and didactic learning in the above-mentioned areas. The
current study had three phases: Phase I (qualitative); Phase II (quantitative); and Phase III (pilot intervention).
The PI conducted a qualitative study to explore the perceptions of aging with HIV within the context of a history
of CSA; and a quantitative study to assess the relationship between CSA, mediators such as adaptive coping,
substance use, depressive symptoms, and outcomes such as ART adherence. We have completed Phases I
and II and are currently in Phase III. Phases II and III were delayed due to the COVID-19 pandemic. The project
aligns well with the NIMH HIV/AIDS priorities (NOT-OD-15-137), by meaningfully including HIV
outcomes/endpoints and examining health and social issues within the context of living with HIV.

Public health relevance
Project Narrative HIV/AIDS continues to be a major public health issue for older adults, and currently, more than half of people living with HIV in the US are 50 and older. The K01 award has provided training and research opportunities to the PI in the areas of developing trauma-focused interventions, mixed-methods approaches, the intersection of HIV and aging, the syndemic of HIV and CSA, and specific longitudinal data analytic techniques for clinical trials. This supplement will provide additional funding for protected time for the PI to complete Phase III (pilot intervention phase) to administer a trauma-informed intervention for older adults living with HIV.